Dodecafluoropentane emulsion (DDFPe), NanO2™ as Cerebroprotectant in Ischemic Stroke

ABSTRACT / PROJECT SUMMARY
Stroke affects more than 795,000 patients per year in the US and kills approximately 40,000. Long-term medical
care expense for stroke in the US, costs over $34B per year. Large vessel occlusion (LVO) stroke accounts for
almost 40% of ischemic strokes but causes 95% of mortality and 62% of long-term dependence. Mechanical
thrombectomy (MT), or a combination of MT and tPA, has emerged as standard of care treatment of LVO stroke.
Up to 60% of thrombectomy patients are first evaluated at spoke hospitals and transferred to hub hospitals for
MT. `Time is brain' following stroke, the sooner therapy can be instituted, the greater the likelihood of preserving
neurological function. A therapy that could be rapidly deployed in all stroke patients to preserve the brain could
provide enormous potential benefit to stroke patients.
NanO2TM (aka dodecafluoropentane emulsion, DDFPe) significantly decreased stroke volume (SV), by about
85%, and improved neurological assessment score (NAS) in rabbits when administered IV up to 3 hours following
stroke and also improved SV and NAS in permanent rat MCAo. In a randomized, placebo-controlled Phase Ib/II
clinical trial of acute ischemic stroke, in which patients receive standard reperfusion therapy, NanO2 was safe at
all dose levels. The higher doses of NanO2 caused significantly better modified Rankin Scale (mRS) at 30 and
90-days post stroke. Early administration of NanO2 (<5 hours from onset) presented with significantly better NIH
Stroke Scale (NIHSS) scores. NanO2 is active at very low doses (e.g. 0.1 to 0.17 mL of 2% w/vol emulsion per
kg body weight) and clears via exhalation with a terminal half-life of about 90 minutes in humans. NanO2 was
previously tested as an ultrasound contrast agent in 2,230 patients and was considered safe and approvable by
the FDA and EMEA. The Specific Aims are 1) to manufacture DDFPe GMP for SPAN studies and to scale-up
GMP manufacturing, 2) to test drug in tMCAo models in lean, adult and aged Wistar rats and 3) to perform
studies in obese, diabetic Zucker rats and spontaneously hypertensive rats.
Expected Outcome: NanO2 will show great efficacy in rodent tMCAo models enabling this drug to be considered
as a candidate for entry into clinical trials in ischemic stroke sponsored by StrokeNet.

Public health relevance
PROJECT NARRATIVE Stroke affects more than 795,000 Americans each year, kills approximately 140,000 and costs the US $34B peryear; large vessel occlusion (LVO) strokes account for almost 40% of ischemic strokes but cause 95% of mortalities and 62% of long-term dependence. Mechanicalthrombectomy (MT) has emerged as standard of care treatment for LVO stroke but MT is only available at specialized hospitals. DDFPe decreases stroke damage by about 85%, with potential to improve outcomes in stroke patients allowing time for treatment with MT. SPAN is a new program that will test promising agents to improve outcomes in stroke; we propose that SPAN test DDFPe.